New Mechanisms of Mitochondrial Toxicity: Focus on Antibacterial Agent Cetylpyridinium Chloride Effects on Immune and Barrier Cells

PROJECT SUMMARY/ABSTRACT
CPC is increasingly found at high doses in hygiene, cleaning, pharmaceutical, and food products and is a
triclosan replacement but is several-fold more mitotoxic than it and other banned mitotoxicants. Mounting
evidence suggests CPC is bioavailable, retained in tissue, toxic to eukaryotes at low doses, and present in
humans. Mitochondrial dysfunction/deformation lead to neurological, immunological, and other diseases. We
discovered that exposure-relevant, non-cytotoxic CPC doses potently perturb mitochondria (ATP, morphology,
oxygen consumption) and cause Ca2+ efflux from mitochondria, but the mechanisms remain unknown. This
project will determine the underlying mechanisms and outcomes of CPC mitochondrial toxicity and, critically,
will promulgate new general mechanisms of mitotoxicity. Our preliminary data show CPC impedes multiple
electron transport chain (ETC) components. CPC also suppresses immune cell signaling via interference with
phosphorylation, Ca2+ dynamics, and protein binding to key signaling lipid phosphatidylinositol 4,5-
bisphosphate (PIP2). Preliminary data reveal CPC disruption of PIP2 diffusion and cluster properties at the
plasma membrane. PIP2 is also found at the outer mitochondrial membrane and its disruption leads to
mitochondrial fission--though understanding of PIP2’s mitochondrial biology is in its infancy. We hypothesize
that CPC interferes with PIP2, phosphorylation, Ca2+, mitochondrial reactive oxygen species (mtROS), and
specific ETC Complexes/associated lipids and enzymes, thus disorganizing mitochondrial shape and function.
Using immune (mast and T cells) and barrier (skin, oral, GI) cells, we will assess CPC effects on the ETC using
electron flow, qPCR, Western blotting (WB), and measures of mtROS and cardiolipin. ETC disruption
outcomes (ATP, glycolysis, lactic acid) will be determined. Kinetics of TCA enzymes in the presence of CPC
will be assessed. Super-resolution fluorescence photoactivation localization microscopy will interrogate
nanoscale CPC effects on mitochondrial morphology and PIP2 clusters and protein interactions at
mitochondria, revealing the fundamental biology of this critical signaling lipid at the mitochondrion. Confocal
imaging will provide another perspective, including mitochondrial translocation in the cell. We will assay CPC
effects on mitochondrial fusion/fission proteins with qPCR, confocal of subcellular dynamics, and WB, including
of phosphorylation status. We will determine the mechanism by which CPC affects the AMPK/mTOR pathway,
which leads to mitochondrial fission, by assessing phosphorylation status with WB. We will extend the findings
with a proven animal model for mitochondrial research, C. elegans, assessing CPC effects on mitochondrial
stress responses, mitochondrial membrane potential, and dopaminergic neurodegeneration. This research will
uncover the mechanisms underlying CPC disruption of mitochondrial function in order to fulfill an urgent need
by providing insights into CPC effects on environmental human health. It will also define new general modes
of mitotoxicity for consideration in toxicity testing workflows.

Public health relevance
PROJECT NARRATIVE CPC is increasingly found at high doses in hygiene, cleaning, pharmaceutical, and food products and is a triclosan replacement but is several-fold more mitotoxic than it and other banned mitochondrial toxicants. We have discovered that CPC is a potent mitochondrial toxicant, and the proposed research will employ molecular, biochemical, and biophysical tools, including organismal studies in C. elegans and super-resolution fluorescence microscopy, to unravel the mechanisms by which CPC harms mitochondria. This research will fulfill an urgent need by providing insights into CPC effects on environmental human health and will define new general modes of mitotoxicity for consideration in toxicity testing workflows.